Chemical Synthesis of Biologically Significant Polysaccharides via LivingPolymerization

Chemical Synthesis of Biologically Significant Polysaccharides via Living Polymerization
Polysaccharides are ubiquitous in biology and play indispensable roles in a variety of biological processes, such
as energy storage and utilization, structural support and protection of cells, lubrication, signal transduction, and
immune modulation. Owing to these crucial bioactivities, polysaccharides are a promising class of biomaterials.
Polysaccharides extracted from natural sources are often highly heterogeneous and structurally complex,
creating a significant barrier for establishing an understanding of structure-function relationships of
polysaccharides and their utilization in various applications. While recent advances in stepwise glycan assembly
techniques have enabled researchers to access chemically defined complex glycans, these procedures are often
labor-intensive, resource-demanding, and scale-limited. In this proposal, we aim to develop a chemical synthesis
platform for the facile and scalable synthesis of a variety of biologically significant polysaccharides via living
cationic ring-opening polymerization. These polysaccharides include linear and branched glucan, mannan,
arabinan, arabinomannan, poly-N-acetylglucosamine, and polyglucuronic acid. Our published prior works have
shown that scalable synthesis of polysaccharides that possess native monosaccharide repeating units and
glycosidic linkages, precisely controlled molecular weight, dispersity, chain-end groups, and chain architectures
can be facilely achieved via living polymerization (Nat. Chem. 2023, 15, 1276-1284; J. Am. Chem. Soc. 2024,
146, 7963-7970). These promising results provided strong support to the feasibility of this project, allowing us to
pursue all three of its distinct aims. In Aim 1, we will probe the mechanistic features of the living cationic ring-
opening polymerization of 1,6-anhydrosugars and conduct mechanism-guided development of reaction
conditions (e.g., catalysts, co-catalysts, chain transfer agents, etc.) toward enhanced reactivities and
stereospecificity. In Aim 2, we develop substrate-controlled living cationic ring-opening polymerization to
generate a variety of biologically significant polysaccharides with stereospecific glycosidic linkages, well-
controlled molecular weights, and defined chain-end groups. In Aim 3, we will demonstrate the utility of the
polysaccharides generated from living polymerization as immune modulatory biomaterials. We will investigate
the receptor-dependent uptake of the polysaccharide-conjugated nanocarriers and the selective activation of
immune cells derived from human primary monocytes. Taken together, the proposed research aims to greatly
expand the toolkit for the chemical synthesis of polysaccharides and empower researchers to access tailor-made
polysaccharides in sufficient scales for applications in biomaterials science and immune engineering.

Public health relevance
Project Narrative Polysaccharides are ubiquitous in biology and also play important roles in disease, but the highly heterogenous nature of polysaccharides extracted from natural sources has hampered its functional studies. This project will develop a chemical synthesis platform for the facile and scalable synthesis of a variety of biologically significant polysaccharides with chemically defined structures. This project will also demonstrate how polysaccharide- based nanomaterials can be used to regulate the immune system, highlighting their potential therapeutic applications in immunotherapy for conditions ranging from cancer to autoimmune diseases.